Developing research training in Zambia to address the epidemic of cardiovascular disease and mental illness amongst HIV infected populations.

Project Summary/Abstract: The overarching goal of this D71 planning grant is to develop a
D43 research-training program in cardiac disease and mental illness amongst HIV infected
individuals enrolled in the National HIV Care and Treatment Program in Zambia. In 2018,
1.2 million people in Zambia were living with HIV1. In 2016, life expectancy for men was 60
years and for women 64 years, a considerable increase from 49.4 years in 2012, partly due
to improved access to antiretroviral treatment (ART). 2 However, despite the considerable
increase in life expectancy, mortality amongst the HIV infected population remains significant.
Non-communicable diseases (NCDs), in particular cardio-vascular disease (incorporating
hypertensive heart disease, myocardial infarction and congestive cardiac failure), aging and
mental illness are increasingly responsible for high morbidity and mortality in low- and middle-
income countries (LMICs) such as Zambia. CIDRZ, an indigenous research organization in
Zambia, has been leading the efforts to establish and maintain high quality, comprehensive
care for HIV infected individuals across the country. The significant investment into HIV
services (including PEPFAR) have resulted in a cadre of well trained, skilled and confident
HIV care providers and clinicians. However, the specificity of their training has meant that
there is a dearth of trained researchers and investigators to identify the relevant research
questions and also a shortage of competent and trained clinicians to deal with significant co-
morbidities including diabetes, cardiovascular disease, aging and, of note, mental health
issues. More recently, these gains are being eroded by the outbreak of SARS-CoV-2 infection
whose impact on HIV-infected individuals particularly in our resource constrained setting
remains unknown. CIDRZ, in collaboration with Washington University in St. Louis, proposes
to partner with the University of Zambia, the University of Lusaka, Levy Mwanawasa Medical
University, the Ministry of Health, and the National Health Research Authority to establish a
training platform for ongoing high-quality HIV/ NCD research. We are requesting funding under
this D71 to prepare for, and ultimately construct, a D43 that would aim to: 1. Increase the pool
of qualified, competent researchers and principal investigators; 2. Increase and enhance
locally-generated NCDs prevalence and risk factor data amongst HIV infected individuals; 3.
develop dissemination and implementation strategies and 4. Develop collaborations with other
research institutions and universities both locally and within the sub-region to leverage off
current capacity and enhance the research capability.

Public health relevance
Project Narrative: Adequate management of, and research around non-communicable diseases amongst HIV infected individuals in Zambia remains a challenge. This D71 planning grant is to develop the required components of an application for a comprehensive D43 multispecialty research-training program that focuses on cardiovascular disease (CVD) and mental health in HIV infected individuals (adults and children) living in Zambia.Our currently funded research projects will serve as catalytic impetus for development of hands-on robust training programs in HIV and associated NCDs.